Molecular mechanisms underlying force transduction at cellular adhesion complexes

The overarching goal of this project is to understand how molecular-scale interactions at cellular adhesion
complexes dictate the organization of cells and tissues. In the first portion of this project, we focus on the
proteins that make up adherens junctions (AJs) and tight junctions (TJs). AJs and TJs link the cytoskeletons of
neighboring cells and allow epithelial tissues to fulfill their essential function as physical barriers, respectively.
Importantly, these complex molecular assemblies are exquisitely responsive to the mechanical forces
generated during embryonic development and tissue repair, and in the context of diseases such as cancer and
heart disease. However, only a few of the protein-protein interactions that make up these adhesion complexes
have been characterized biochemically, and even less is known about the underlying mechanisms by which
these structures respond to mechanical load. This lack of quantitative data presents an unavoidable roadblock
in the collective effort to understand how cells build and remodel multicellular tissues.
In the past funding period, we used single-molecule biophysical assays to discover multiple unanticipated
mechanisms by which the proteins present in these complexes sense and respond to mechanical force. Here,
we will build on these results to discover the mechanisms by which AJ and TJ proteins may act to seed larger-
scale organization at the cell and tissue levels. Based on strong preliminary data, we will examine how
adhesion complexes templated by αE-catenin and afadin regulate the assembly of multicellular actomyosin
cables that power collective cellular motions during embryonic development and wound healing. Preliminary
data likewise demonstrate that PDZ domains, a widespread class of protein domains that mediate protein-
protein interactions, can exhibit striking forms of mechanosensitivity. Building on this result, we will elucidate
the function of mechanosensitive PDZ-mediated interactions in controlling the assembly and dynamics of TJs,
and work to discover additional forms of force sensing employed by junctional proteins.
The second portion of this proposal focuses on a class of specialized cellular adhesion complexes that
mediate planar cell polarity (PCP). PCP refers to the long-range, front-back polarization of cells in the tissue
plane. PCP is essential in multiple developmental contexts, and aberrations in PCP signaling are a prevalent
source of birth defects. Previous work shows that the core PCP components assemble into clusters at cell-cell
junctions, with specific proteins asymmetrically localized to opposite sides. The molecular mechanisms that
mediate the induction of this key asymmetry have remained elusive. Here, we will combine the power of
Drosophila genetics with quantitative imaging approaches to test the hypothesis that multivalent protein-protein
interactions within individual clusters lead to a nonlinear increase in asymmetry with cluster size. In total, work
across these two areas will greatly expand our understanding of how the interactions of individual proteins
within cellular adhesion complexes generate the structure and function of cells and tissues.

Public health relevance
Cells in the human body link to one another via protein complexes that respond to mechanical force in order to maintain tissue integrity, and to remodel tissues during embryonic development. We will determine how key proteins in cellular adhesion complexes and the cytoskeleton respond to force, and how their molecular behavior contributes to processes that shape living tissues. This study will significantly advance our understanding of the molecular events that drive cancer metastasis, in which the loss of cell-cell contacts is a key step, as well as the causes of cardiomyopathies and skin diseases in which cells lose their mechanical integrity.